Mechanisms of Bacterial Lysis Sensing

PROJECT SUMMARY
Matrix-encapsulated communities of bacteria, called biofilms, are ubiquitous in the environment and are
notoriously difficult to eliminate in clinical and industrial settings. Existing within biofilms offers resident
cells protection from threats, such as bacteriophage attacks, phagocytosis by the host immune system,
and antibiotic treatment. However, the fundamental principles by which bacteria gauge environmental
threats to inform biofilm development remain unclear. Recently, my laboratory discovered a novel, threat-
agnostic mechanism, by which bacteria sense endangerment and respond by forming protective biofilms.
The underlying mechanism is a process we call “lysis sensing,” whereby surviving cells sense a signal
released during the death of related species and, in turn, initiate biofilm formation. Going forward, the
overarching goal of our research program is to develop a comprehensive understanding of lysis sensing
across scales, from molecular mechanisms to population-level dynamics. To realize this vision, we will
leverage a multidisciplinary approach, involving molecular microbiology, biochemistry, microscopy,
computation, and automation. To reveal how lysis-sensing receptors connect threat assessment to the
formation of protective biofilms, we will biochemically characterize the Vibrio cholerae lysis-sensing
receptor-signal complex that we recently uncovered. To determine how lysis signaling functions in
conditions that approximate microbiomes, we will combine experimental and theoretical approaches to
examine lysis sensing in homogeneous, spatially structured, and multi-species communities. To assess
the pervasiveness and diversity of lysis sensing, we will identify lysis-sensing pathways in additional
clinically relevant bacteria using high-throughput imaging approaches that we have pioneered, and we
will follow up to uncover underlying molecular mechanisms. Finally, we will extend our studies beyond
regulation of the biofilm lifecycle to explore other defense mechanisms activated by bacteria in response
to lysis signals. Together, this work will shed light on fundamental concepts by which bacteria undergo
threat assessment to respond to the ongoing challenges faced in their host and environmental niches.
Our research could uncover new strategies for manipulating microbial behaviors in health and disease,
with potential long-term applications for biocontrol, therapeutics, and microbial ecology.

Public health relevance
PROJECT NARRATIVE Bacterial "lysis sensing," recently uncovered by my lab, allows bacteria to detect signals released through the death of related species and, in response, form multicellular communities called biofilms for protection. Here, we propose to utilize a multidisciplinary approach to uncover the molecular and ecological principles of lysis sensing in bacterial communities. This work will reveal fundamental concepts by which bacteria undergo threat assessment to respond to the ongoing challenges faced in their host and environmental niches.